Post-transcriptional Regulation Requires Phosphorylation of HuR in Glioma

at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page 1 Description,